Uncovering astrocyte contributions to neuropathic pain

Project Summary
Chronic pain poses a significant societal burden, affecting over 50 million Americans. New cases of chronic pain
occur more frequently in the U.S. than diabetes, depression, or high blood pressure. Approximately 20 percent
of chronic pain patients experience neuropathic pain due to nervous system injury or disease. Current
neuropathic pain management relies on repurposed drugs with uncertain efficacy and known side effects,
necessitating safer and more effective pharmacologic and non-pharmacologic approaches. However, existing
knowledge gaps in basic research have hindered the development of more effective treatments. Understanding
the mechanisms underlying neuropathic pain and how interventions interact with these mechanisms is
imperative. The spinal cord plays a crucial role in neuropathic pain; however, technical limitations of traditional
research approaches have left the mediators of this signaling incompletely understood. While significant attention
has been directed toward neuronal cell types and circuits contributing to neuropathic pain, the contributions of
non-neuronal cells are less understood. Astrocytes, glial cells of the central nervous system, cover all gray and
white matter regions, allowing them to affect various aspects of neural circuit function, including neuronal
excitability, synchrony, and synaptic plasticity. Accordingly, there is growing interest in better understanding
astrocytes' role in neuropathic pain pathology. Nonetheless, the precise relationship between spinal astrocyte
excitation and neuronal spiking, plasticity, or behavioral responses remains incompletely understood.
Preliminary data in an established neuropathic pain model indicate that astrocyte-targeted interventions can
abrogate mechanical and thermal hypersensitivity after nerve injury. Based on these findings, it is hypothesized
that peripheral nerve injury disrupts neuron-astrocyte communication, promoting abnormal neural circuit activity
and plasticity, and regulating astrocyte function can mitigate neural circuit dysfunction and pain behavior. This
project aims to 1) determine in detail how peripheral nerve injury alters dorsal horn astrocyte function, 2) elucidate
how targeted interventions control dorsal horn astrocyte function after nerve injury, and 3) characterize how
targeted modulation of astrocyte function controls abnormal neuronal activity, connectivity, and pain behavior
following nerve injury. Ultimately, this work will yield new insights into the manifestation of neuropathic pain at
synaptic, cellular, and circuit levels, providing crucial information for the development of more effective
pharmacologic or non-pharmacologic interventions in the future.

Public health relevance
Project Narrative Neuropathic pain is a severe, often treatment-resistant form of chronic pain caused by nervous system lesions or diseases. Using a wide range of experimental approaches, this project aims to better understand the molecular, cellular, and circuit-level mechanisms of neuropathic pain and evaluate targeted interventions for more effective treatments in the future.